Building Research in Implementation and Dissemination to close Gaps and achieve Equity in Cancer Control (BRIDGE-C2) Center

OVERALL PROJECT SUMMARY
The Building Research in Implementation and Dissemination to close Gaps and achieve Equity in Cancer
Control (BRIDGE-C2) Center will take on the grand challenge of advancing implementation science to
improve cancer screening and prevention in underserved populations. This work is urgently needed
because cancer screening and prevention disparities exist with regard to delivery of evidence-based
interventions (EBIs). Effective strategies to improve implementation of EBIs in primary care community health
centers (CHCs) that can eliminate these disparities are not known or poorly understood. Implementation
science can contribute new knowledge that will transform CHCs' ability to serve the nation's most vulnerable
populations. The BRIDGE-C2 Center will: 1) create a sustainable infrastructure for developing, conducting, and
continuously evaluating implementation strategies that enhance primary care's ability to equitably deliver
evidence-based cancer screening and prevention interventions to all people, emphasizing closing care gaps
for vulnerable populations; 2) build capacity and training opportunities, and engage a multi-disciplinary team of
implementation science and methods experts, to facilitate the development of innovative approaches relevant
to our grand challenge; and 3) identify strategies to improve implementation of cancer screening and
prevention EBIs in primary care, and conduct research / develop pragmatic methods to tailor, enhance, and
support the adoption and sustainability of these strategies. We will build on the strong established partnerships
between researchers at Oregon Health & Science (OHSU) primary care, the OHSU Knight Cancer Institute,
and the OCHIN Implementation Laboratory (a well-established national network of >500 CHCs that share an
electronic health record through the OCHIN Practice-Based Research Network). The BRIDGE-C2 Center will
conduct pilot studies that develop and test strategies to improve implementation of EBIs, rapidly scale up
successful pilots to conduct large scale pragmatic trials, and widely disseminate effective innovations to
primary care practices caring for underserved populations. Woven throughout these activities will be the
Center's focus on mentoring and training early career implementation scientists and leveraging collaborations
to increase implementation science capacity. The Center's Administrative Core will serve as the nucleus that
bridges the Research Program and Implementation Laboratory, providing support for research activities,
leadership, governance, investigator development, dissemination, evaluation, and a connection to the national
ISCCC network. Our first two research pilots aim to improve cervical cancer screening and follow-up care and
tobacco cessation. Our first two methods pilots will create novel capabilities to predict needed implementation
support based on provider and practice characteristics. We will spread our discoveries and create mechanisms
for widely disseminating our findings and innovations to scientific, professional, and community networks to
increase implementation of cancer screening and prevention EBIs and decrease health disparities.

Public health relevance
NARRATIVE The BRIDGE-C2 Center will take on the grand challenge of advancing implementation science to improve cancer screening and prevention in underserved populations. This work is urgently needed because cancer screening and prevention evidence-based interventions are not equitably delivered.